CBT@EmTech - CardioVascular Biomechanics Training Program at Emory and GaTech

Project Abstract/Summary
This T32 proposal is for the support of an interdisciplinary, pre-doctoral training program entitled “Cardiovascular
Biomechanics and Mechanobiology Training Program at Emory University and Georgia Tech” (CBT@EmTech).
The goal of CBT@EmTech is to develop an innovative graduate program to train the next generation of
cardiovascular leaders at the intersection of cardiovascular biomechanics, mechanobiology, medical imaging,
computational modeling, medical devices, therapeutics discovery and delivery, and data science to address
translationally relevant cardiovascular biomechanics, pathophysiology, therapies, and diagnostics. The Program
is built on a long history of ground-breaking research applying biomechanics to the field of cardiovascular disease
at Emory and Georgia Tech. The Program leverages our long-standing successes in research and education in
cardiovascular biomechanics and medicine across Emory and Georgia Tech. CBT@EmTech trainees will be
recruited from an applicant pool of >80 diverse groups of eligible students, including women and
underrepresented minorities from the Joint Department of Biomedical Engineering (BME) at Georgia Tech and
Emory and the Interdisciplinary Bioengineering (BioE) Graduate Program at Georgia Tech. BioE graduate
students come from various home Departments, including Electrical and Computer and Mechanical Engineering
at Georgia Tech and Departments of Mathematics, Computer Science, and Chemistry at Emory. We request
support for six students per year over five years to provide two years of support for each student in years 1 and
2 of their PhD program. In addition to the T32-supported positions, two additional students per year will be
supported, one by Emory and the other by Georgia Tech, to help further train a diverse group of students. All the
trainees will do lab rotations in the first year to select a mentor and co-mentor, one from medicine/biology and
the other in engineering/data science, or vice versa, or one from biology/engineering/data science and the other
from medicine. This will train and encourage our students to undertake multidisciplinary, collaborative, and
translational research. Our trainees will take 1) foundational courses in biosciences, engineering, and data
science, 2) integrative biomedical engineering courses, 3) ethics and diversity training, 4) communication and
professional development, and 5) the Advanced Seminars in Cardiovascular Biomechanics and Medicine class
that include clinical observations. CBT@EmTech will enhance the diversity of the workforce in the cardiovascular
biomechanics and disease field and train them to be inclusive leaders. Our trainees from diverse backgrounds
are expected to become leaders in addressing unmet translational and clinical needs in cardiovascular
biomechanics, pathophysiology, therapies, and diagnostics.

Public health relevance
Project Narrative This interdisciplinary program in Cardiovascular Biomechanics at Emory University and Georgia Tech (CBT@EmTech) will train the next generation of biomedical engineers to study how biomechanics affects cardiovascular diseases. Trainees will receive formal coursework, research training, and professional development that will enable them to apply an integration of engineering, vascular biology, data sciences, and biosciences to unsolved problems in cardiovascular medicine. We expect these trainees to be thought leaders in the diagnosis and treatment of cardiovascular disease.